Spatio-temporal regulation of pulmonary neutrophil plasticity

PROJECT SUMMARY / ABSTRACT
Due to the lungs’ constant exposure to environmental irritants and airborne pathogens,
polymorphonuclear neutrophils (PMN) play an essential role in the pulmonary host defense system to rapidly
respond to pathogens such as bacteria and fungi. The lungs are the organ responsible for gas exchange between
blood and air, and the minimum functional unit, alveoli, have a characteristic structure with thin capillaries
stretched in close proximity. This proposal is based on the postulate that these characteristic lung micro-
environmental structures spatio-temporally regulate neutrophil plasticity during acute lung inflammatory injury.
To support this proposal, we have developed a Computer-Vision Stabilized intravital imaging (CoVSTii) system
for highly efficient mouse lung imaging and have quantified PMN motility and activation dynamics during acute
inflammatory lung injury. My supporting data show that PMNs recruited into the lungs extrude their nuclei and
become PMN cytoplasts (PMNcyts) without nuclei. Surprisingly, those cells efficiently deform their cell shape due
to the absence of nuclei and migrate faster than normal PMNs in spatially restricted infected areas of the lung
(PMN rapid response). During this process increased calcium influx and mitochondrial polarization, probably as
result of cell deformation, were also directly observed. On the other hand, PMNcyt activations disappeared during
prolonged injury condition (PMN paralysis), leading to the fundamental question of whether they can be restored
by intervention at the molecular level. I posit that these findings are due to lung-specific PMN dynamics caused
by the characteristic structure of the lung and that understanding this phenomena may provide an interesting
perspective on the paradox of acute lung injury (ALI)/acute respiratory distress syndrome (ARDS), which is
characterized by excessive uncontrolled PMN. In Aim 1, I will elucidate the spatio-temporal regulatory
mechanisms of pulmonary PMN nuclear extrusion and rapid PMNcyt activation. Here, I will carry out quantitative
lung intravital imaging to visualize PMN motility and organellar dynamics such as nucleus/mitochondria and
signaling dynamics such as role of calcium in controlling these functions. I will focus on the involvement of Piezo1
(mechanosensitive calcium channel present in myeloid cells) and Protein Arginine Deiminase 4 (PAD4) (a critical
calcium dependent enzyme mediating NETosis, resulting in formation of neutrophil extracellular traps (NETs)
composing of genomic DNA and bactericidal components) pathway. I will define the role of these pathways in
lung using dynamics imaging system/drug modulation/genetically engineered mice. In Aim 2, I will address the
spatio-temporal regulatory mechanisms of paralyzed PMNcyts found in distal lung microvessels and ways to
reactivate these cells. Here, I will carry out quantitative lung intravital imaging of paralyzed PMNcyts. I will focus
on Piezo1-Hif1a (Hypoxia-inducible factor-1a, a Piezo1 dependent transcriptional regulator) pathway that may
reanimate paralyzed PMNcyts. I will also attempt re-energize paralyzed PMNcyts via mitochondrial transplantation
and mitochondrial nutrient delivery.

Public health relevance
NARRATIVE Neutrophils are white blood cells that kill pathogens in infected tissues. I believe that these cells achieve their rapid host defense function by releasing their nuclei to facilitate cell deformation when working in the spatially restricted lung. This research will elucidate the mechanism of lung micro-environment specific neutrophil regulation and lead to more ideal therapies for patients with pulmonary infections and acute lung injury.